Alpha7 Nicotinic Receptor: Structures and Coupling with Intracellular Proteins

The alpha7 nicotinic acetylcholine receptor (α7nAChR) has emerged as a unique player in the infection and progression of COVID-19, which has caused more than 325,000 deaths. α7nAChR links tobacco smoking to major clinical manifestations in COVID-19, including respiratory infection, anosmia, systemic coagulopathy, and cytokine storm. Several sequences of SARS-CoV-2 are found to be homologous to α-bungarotoxin and α- cobratoxin, potent antagonists of α7nAChR. These findings support the hypothesis that SARS-CoV-2 interacts directly with α7nAChR, inhibits its function, and consequently dysregulates the inflammatory responses mediated by α7nAChR. The experimental evidence is urgently needed to correctly establish the role of α7nAChR in COVID-19 and to understand nicotine’s detrimental or protective effects on the onset and progression of COVID- 19. With permission from the NIDA (Dr. Roger Little, Deputy Director, Division of Neuroscience and Behavior), we seek Administrative Supplement support to address several key questions about the involvement of nicotine and α7nAChR in COVID-19. Specifically, we propose to elucidate: (1) where and how SARS-CoV-2 proteins interact with α7nAChR and how nicotine alters such interactions; and (2) how SARS-CoV-2 proteins affect intracellular signaling pathways downstream of α7nAChR that lead to upregulation and transactivation of pro- inflammatory cytokines, and how nicotine modulates the outcome of this process. Considering the widespread expression of α7nAChR in various organs and the significant regulatory role of α7nAChR in the cholinergic anti- inflammatory pathway, our research outcomes can potentially lead to new treatment strategies to combat COVID-19.

Public health relevance
Narrative: The α7 nicotinic acetylcholine receptor (α7nAChR) has widespread expression in various organs and plays a significant regulatory role in the cholinergic anti-inflammatory pathway. The proposed studies aim to elucidate how SARS-CoV-2 interacts directly with α7nAChR, inhibits its function, and consequently dysregulates the inflammatory responses mediated by α7nAChR. The goal is to fill current knowledge gaps to contribute to new treatment strategies in combating COVID-19.